Neuroimaging Cholinergic Mechanisms of Fear Extinction in PTSD

PROJECT SUMMARY
Post-traumatic stress disorder (PTSD) is a deeply debilitating disorder with severe public health burden. Yet,
current pharmacological treatments are glaringly suboptimal. The α7 nicotinic acetylcholine receptor (nAChR) is
a salient molecular target for PTSD therapeutics. Acetylcholine regulates fear learning and memory processes
that are impaired in people with PTSD, and α7 nAChR density is reduced by chronic stress in preclinical models.
Despite this compelling evidence, the role of α7 nAChRs in the pathophysiology of PTSD in humans is not fully
understood. To address this gap, this proposal will characterize α7 nAChR contributions to behavioral and neural
markers of fear learning in trauma-exposed participants representing the full spectrum of PTSD severity. Using
[18F]ASEM, a positron emission tomography (PET) radioligand specific to α7 nAChRs, we obtained exciting
preliminary data indicating lower α7 nAChR availability in people with PTSD that is associated with the severity
of PTSD symptom clusters. Further, lower α7 nAChR availability in amygdala corresponded to weakened
functional connectivity of the amygdala and ventromedial prefrontal cortex, which is a key circuit that underpins
fear learning processes. Motivated by these exciting data, the primary objective of this project is to characterize
α7 nAChR contributions to fear extinction learning and circuitry in PTSD. To achieve this goal, we will recruit 80
participants with trauma exposure sampled across the full dimensional spectrum of PTSD symptoms. All
participants will be scanned with [18F]ASEM PET and participate in an established fear reversal task with
concurrent functional magnetic resonance imaging (fMRI). The acquired data will be used to address three
Specific Aims. AIM 1 will determine if people with PTSD have lower α7 nAChR availability than trauma exposed
controls, and which PTSD symptom cluster severities correspond to lower α7 nAChR availability. AIM 2 will
determine if lower α7 nAChR availability in amygdala predicts impaired learning rates during fear extinction. AIM
3 will determine if lower α7 nAChR availability in amygdala predicts weaker vmPFC-amygdala connectivity during
fear extinction. A final analysis will determine if amygdala α7 nAChR availability mediates the relationship of
amygdala-vmPFC connectivity with fear extinction learning rates, assessing these receptors a mechanism
underlying disrupted fear extinction circuits in PTSD. The findings will determine α7 nAChR roles in the
pathophysiology of fear extinction and its brain circuits in living people, informing future therapeutic development
to address fear extinction impairments that underlie chronic PTSD symptoms.

Public health relevance
PROJECT NARRATIVE This project will measure levels of a brain nicotinic receptor in people exposed to trauma, half of them with PTSD. Relationships of these receptors with PTSD symptoms and fear learning will be investigated. The findings will advance the basic neuroscience understanding of factors contributing to distinct symptoms, informing future development and evaluation of pharmacotherapies for people with PTSD.